Immuno-Oncology Translation Network: Data Management and Resource-Sharing Center at RPCI

This application is being submitted in response to PA-20-272
Project Summary
While several innovative and creative anti-cancer therapies have shown promising results, a significant
expansion of their clinical use will require collaborative efforts to elucidate resistance mechanisms, exploit
tumor sensitivity, map cancer dependence, discover new targets, identify predictive biomarkers, evaluate
combination therapies, and develop real-time monitoring approaches. Leveraging cutting-edge multi-
disciplinary team approaches, we will support the NCI Drug Resistance and Sensitivity Network (DRSN) to
understand and combat mechanisms of tumor resistance and to exploit tumor sensitivity to anti-cancer
therapies. Our strategy is to serve as an administration, communication, collaboration and analysis hub to
coordinate the DRSN’s network-wide studies, focusing on reducing barriers to domain expertise, improving
the productivity of DRSN investigators, maintaining a high standard for data harmonization and integration,
designing and implementing rigorous analytical strategies, and fostering a collaborative and supportive
research community.
An experienced, multidisciplinary team has been assembled to pursue five Specific Aims: First, we will
provide a centralized administration infrastructure to coordinate DRSN activities, building upon the Immuno-
Oncology Translational Network (IOTN) Data Management and Resource-sharing Center (DMRC)’s well-
functioning infrastructure that currently coordinates network studies under the umbrella of the NCI Cancer
Moonshot initiative. Second, we will actively promote the DRSN and foster trans-consortium interactions,
where we will leverage the IOTN DMRC’s demonstrable experience in Cross-Moonshot outreach and
Bioconductor’s decades-long record in community-wide engagement. Third, we will provide multidisciplinary
expertise to support DRSN collaborative research, leveraging four of the Roswell Park CCSG’s shared
resources: Biostatistics, Bioinformatics, Data Bank and BioRepository, Bioanalytics, Metabolomics &
Pharmacokinetics. Our analytic support will be armed with professional IT staff and informed by an
experienced anti-cancer therapeutic researcher team. Fourth, we will develop innovative multi-omics data
integration methods to enhance DRSN’s research capacity, capitalizing on the well-respected and highly-
successful Bioconductor project. Fifth, we will disseminate resources developed in the DRSN to the broader
community, unleashing the full potential of DRSN activities. Taken together, we envision our CC, in close
collaboration with the DRSN components, will allow us to conduct highly effective and innovative
translational studies to address the significantly unmet needs related to anti-cancer therapeutics, and fulfill
the expectations and guiding principles of NCI Cancer Moonshot initiative.

Public health relevance
Project Narrative While several innovative and creative anti-cancer therapies have shown promising results, a significant expansion of their clinical use will require collaborative efforts to elucidate resistance mechanisms, exploit tumor sensitivity, map cancer dependence, discover new targets, identify predictive biomarkers, evaluate combination therapies, and develop real-time monitoring approaches. Leveraging cutting-edge multi- disciplinary team approaches, we will support the NCI Drug Resistance and Sensitivity Network (DRSN) to understand and combat mechanisms of tumor resistance and to exploit tumor sensitivity to anti-cancer therapies.